Investigating the mechanism of K17-mediated immunosuppression in papillomavirus-induced cancers

PROJECT SUMMARY/ABSTRACT
My long-term career goal is to become an independent scientist in an academic research institution. My research
interest focuses on investigating novel molecular mechanisms underlying immunosuppression in tumor
microenvironment to provide new therapeutic targets and approaches to improve cancer immunotherapy
treatments. The proposed studies for the K22 award will form the foundation for my future research as I transit
from a researcher to a junior faculty member.
High risk human papillomaviruses (HPV) cause 5% of all human cancers, including majority of cervical cancer,
anal cancer, skin cancer and a growing fraction of oropharyngeal cancer. We have used mouse papillomavirus
(MmuPV1), a virus thought to model HPV infection in laboratory mice, to study host factors that contribute to
persistent viral infection, a risk factor for tumor progression to cancer in papillomavirus-induced neoplastic
diseases. We have identified stress keratin 17 (K17) as a critical host factor exploited by MmuPV1 to establish
persistent infection. The same mechanism is used in HPV negative head and neck cancers in mice and in
humans to modulate tumor immune microenvironment and mediate resistance to immune checkpoint blockade
(ICB) therapy. The goal of this proposal is to reveal the molecular mechanisms underlying K17-mediated immune
suppression using MmuPV1 as an infection-induced neoplastic disease model. Based upon what we have
learned so far from my postdoctoral studies, we hypothesize that K17 functions through downregulating tumor
cell MHC class II expression, and polarizing macrophages in the tumor microenvironment to prevent T cell
infiltration. I propose the following aims:1) define the role of immune cell subsets, especially CXCL9-producing
macrophages, in K17-mediated immune evasion in the context of papillomavirus-induced disease; 2) determine
tumor cell-intrinsic mechanisms associated with K17 expression that contribute to immune evasion.
In Aim1, I propose to test the importance of macrophages in K17-mediated immune suppression by
characterizing the macrophage subsets comprehensively through phenotyping and in vivo functional transfer
studies. In this aim, I will continue to collaborate with Dr. Huy Dinh, a computational biologist with a research
interest in tumor immunology, to systemically study other immune cell subsets and tumor-immune cell-cell
interactions that may play a role in K17-mediated immune suppression. In Aim2, I propose to study the tumor
cell intrinsic mechanisms regulated by K17 expression, with a focus on MHC class II expression. Our preliminary
data showed an inverse correlation between tumor cell K17 expression and tumor cell-intrinsic MHC class II
expression. In this aim, I will collaborate with Dr. Huy Dinh on spatial transcriptomic studies to further investigate
how MHC class II expression regulated by K17 affect immune landscape in tumors. What I learned from
proposed studies may have broad impact on many other epithelial-originated cancers where K17 is
overexpressed.

Public health relevance
PROJECT NARRATIVE This research proposal will elucidate mechanisms of immune evasion by papillomaviruses, mediated by induction of stress keratin K17, that permit for persistent infections and consequent cancer. Our studies are aimed at defining new therapeutic approaches to increase T-cell mediated killing of tumors, which will provide insights into how to enhance existing checkpoint blockade therapies by increasing tumor-infiltrating T cells. These studies are highly relevant to public health and will provide important insights for improving immunotherapy efficacy for other types of cancer as well.